Neoadjuvant immunoradiotherapy for HPV mediated oropharynx cancer

Project Summary
HPV mediated oropharynx cancer (HPVOPC) is projected to increase in incidence in the United States over the
next 20 years. Attempts to de-escalate nonsurgical treatment for HPVOPC have not been successful and current
treatment regimens incur significant long-term morbidity. Recently, PD-1 inhibitors received approval as first line
therapy for recurrent/metastatic head and neck squamous cell carcinoma (r/mHNSCC), achieving ~15-20%
overall response rates. However, PD-1 inhibition has demonstrated no benefit in patients with previously
untreated, locally advanced HPVOPC/HNSCC, and emerging neoadjuvant window of opportunity trials
examining PD-1 inhibition have documented only modest response. Targeting stereotactic body radiation
(SBRT) to the tumor while sparing the tumor draining lymphatics may increase the response to PD-1 inhibition
as part of a novel rational therapeutic strategy. In support of this hypothesis, we have shown that ablating tumor-
draining lymphatics blocks the response to PD-1 inhibition and that elective nodal irradiation attenuates antitumor
immunity and T cell infiltration in multiple experimental HNSCC model systems. In addition, we found that early,
but not delayed, lymphatic ablation blocks the response to combined SBRT and PD-1 inhibition, indicating that
an immunologically competent draining lymph node bed is critical to mount effective antitumor immunity after
PD-1 inhibition. We explored this premise in our recent Phase 1 clinical trial in resectable HNSCC patients who
received nivolumab in combination with SBRT to gross tumor volume (GTV), followed by definitive surgical
resection (NCT03247712). Astonishingly, the pathologic complete response rate in HPV+ patients was 90% and
no patient required adjuvant radiation or chemoradiation. In addition, the combination of a CD47 inhibitor
(evorpacept) with PD-1 inhibition shows enhanced response compared to PD-1 inhibition alone in both preclinical
models and in r/mHNSCC. Our overall hypothesis is that preserving the immune-lymphatic axis during
neoadjuvant immunoradiotherapy (NIRT) for HPVOPC will promote anti-tumor immunity, potentiate checkpoint
blockade therapy and reinstate effective cancer immunosurveillance. Therefore, we propose a phase IIb, single
arm clinical trial of neoadjuvant 8Gy x 3 SBRT to GTV followed by combination evorpacept and pembrolizumab
in patients with previously untreated locally advanced, resectable HPVOPC, followed by risk adapted adjuvant
therapy. We specifically hypothesize that combination neoadjuvant SBRT and evorpacept + pembrolizumab will
1) provide >80% complete/major pathologic response in patients with resectable HPVOPC, 2) is safe and will
result in functional and quality of life metrics that are similar or better to those for patients treated with standard
therapy, and 3) enhance cytotoxic CD8 T cell antitumor immunity by driving the priming and expansion of tumor-
reactive T cells along the tumor-immune-lymphatic axis. A high pathologic response rate and favorable
toxicity profile in the proposed trial will support a subsequent paradigm-shifting, randomized phase II
trial comparing nonsurgical treatment with SBRT to GTV followed by immunotherapy versus standard
of care radiation with concurrent cytotoxic chemotherapy.

Public health relevance
Narrative Cancer immunotherapies have led to major treatment breakthroughs for a number of different cancers, but the majority of head and neck cancer patients do not respond to immunotherapies, and clinical responses are often not durable. We have demonstrated that targeting tumors with stereotactic radiation in combination with immunotherapy while sparing draining lymphatics enhances anticancer immunity, resulting in significantly improved response profiles. The research outlined in this proposal will leverage targeted tumor radiation and a combination of anti-CD47 and anti-PD-1 therapy to improve the response to PD-1 inhibitor immunotherapy in human papilloma virus related cancers of the throat.